Oklahoma C. difficile U19 Administrative Core

Project Summary (Administrative Core)
The Administrative Core will manage and oversee all Components of the Oklahoma C. difficile U19 program.
This will include the following responsibilities: coordinate communications between investigators (Project
Leaders and Scientific Core Director); organize group meetings; collect and collate information for progress
reports; prepare file progress reports; and assume responsibility for overall fiscal management. The
Administrative Core will also coordinate outreach activities, including seminar invitations, and coordinate travel
to and participation in the annual U19 meeting. The Specific Aims of the Administrative Core are: Specific Aim
1: To provide administrative management of Oklahoma C. difficile U19 research projects and foster collaboration
between U19 research projects. Specific Aim 2: To provide administrative management of U19 Cores and foster
integration with U19 research projects. Specific Aim 3: To establish an effective working relationship with the
NIAID Project Scientist. Specific Aim 4: To provide scientific oversight for the program, monitor and document
research progress, and ensure reasonable benchmarks are met. Specific Aim 5: To network with NIH-funded
programs at OUHSC and with other awarded U19 C. difficile programs. Accomplishment of these aims will
ensure this Phase 1 U19 has well-managed, programmatic growth and success during the establishment of the
Oklahoma C. difficile U19 program.